Neurotoxic and neurodegenerative risks from chronic exposure to metal mixtures in e-cigarette aerosol

Project summary
The main objective of this project is to investigate the feasibility of using a novel peripheral biomarker—the metal
cargo of circulating brain-derived extracellular vesicles (EVs)—to assess non-invasively metal deposition in brain
due to e-cigarette aerosol exposure. This project is a supplement to an ongoing R01, which investigates the
neurotoxic, behavioral and pathological consequences of metal exposure and metal dyshomeostasis in mice
exposed to e-cigarette aerosol.
The candidate for this supplement is a US citizen of Haitian descent. She graduated from Barnard College
with a B.A. degree in Environmental Science and a minor in Biology. Her enrollment into our MS program at
Columbia University in the Fall of 2022 will increase the representation of Black women in science, which is
particularly lacking. For her research and training, she will be mentored by Drs. Diane Re and Markus Hilpert,
MPIs of the parent grant, and she will receive additional mentorship from Dr. Ana Navas-Acien who is part of the
e-cigarette working group at Columbia University. In the proposed project, the candidate will (1) determine
whether metal content in blood brain-EVs is a longitudinal biomarker of e-cigarette exposure and brain metal
elimination upon exposure to e-cigarette aerosol, (2) investigate whether brain EV metal levels can be used to
non-invasively infer metal burden in the brain of e-cigarette exposed mice, and (3) explore whether genetic
susceptibility to Parkinson's disease (PD) modifies brain EV metal content.
Through the proposed analyses, the candidate will gain experience and skills in: 1) the use of novel EV
biomarkers to study the effects of metal exposure from e-cigarette use on neurodegenerative disease, 2)
statistical analysis of the novel biomarker data; 3) training in animal models of environmental exposures, and 4)
understanding the mechanisms of toxic metal exposure from e-cigarette use on metal homeostasis in the brain
and neurodegenerative disease. The candidate will also receive formal training by taking courses through our
MS program during the regular school year. The candidate and mentors will meet once a week for training and
to discuss progress.
This project could validate the first brain-relevant peripheral biomarker to predict brain metal load of subjects
exposed to e-cigarette aerosol. Based on this study, brain EV metal load could become an established biomarker
of individual neurotoxic risk for vapers and second-hand exposure. The proposed research has also significant
implications for intervention studies to reduce adverse effects of e-cigarette aerosol exposure. Finally, by
providing advanced skills, training and laboratory research opportunities to a Master of Science student with
focus in toxicology, this project will enhance diversity in our research team at Columbia University and down the
road in the fields of toxicology and environmental health sciences.

Public health relevance
Narrative This project will evaluate in an animal model of exposure to e-cigarette aerosol the potential of little capsules, which are produced in the brain and released into the blood circulation to eliminate metals, as potential biological markers (biomarkers) of metal accumulation in the brain of e-cigarette users and environmentally-exposed bystanders. The candidate is a recent BA graduate from Barnard College who will matriculate in the Master of Sciences in Toxicology program at Columbia University Mailman School of Public Health in Fall 2022. The supplement will provide experimental skills, training in animal models of environmental exposure, biomarker and toxicology knowledge through a rigorous MS program to a candidate working toward a career in environmental health research.